Cellular and molecular control of periodontal tissue regeneration

Periodontal diseases (PDs) are major causes of tooth loss and a significant public health burden in the world.
Reconstruction of healthy periodontal tissue damaged by injury or diseases is a major goal of
periodontal treatment. The periodontium supports and invests the tooth and is composed of alveolar bone
(bone lining the too socket), periodontal ligament (PDL), part of the gingiva facing the tooth (dentogingival
junction) and the root cementum. In the periodontal apparatus, the alveolar bone (AB) is connected via
PDL and the gingiva to the tooth in the periodontal crestal region (POCR). Maintaining periodontal
tissue integrity is essential for mammals to maintain tooth functions and prevent the spread of local and
systemic infections via periodontal pocket. Periodontal stem cells have been identified in the periodontal
ligament within the apical PDL space and gingival connective tissue. However, major questions remain
unanswered. First, it is unknown whether there are distinct stem cell populations in the POCR that give rise to
AB, PDL and gingiva. Second, it is unknown how stem cells residing in the POCR are regulated for
homeostatic tissue maintenance and regeneration after injury by coordinating differentiation into distinct cell
lineages. Lastly, it is unknown whether and how the periodontal stem cells are altered in a severe
inflammatory environment that causes periodontal tissue defects, and whether the involved mechanisms can
be employed to achieve more predictable and efficient periodontal tissue regeneration. Elucidating these
fundamental questions will advance current knowledge of periodontal stem cells and promote natural
periodontal tissue regeneration. We are beginning to tackle these key questions in our preliminary studies and
we specifically focus on the POCR in the adult periodontal cervical tissue of the tooth, as this area is
exposed to oral bacteria and other substances and forms front-line protection for the deeper periodontal
and dental tissues, and yet is under-investigated. We have identified periodontal crestal stem cells
(PCSCs), which included Gli1+ cells that played important roles in POCR regeneration. We postulate that the
crestal region contains PCSCs that coordinate periodontal tissue regeneration, and injury-induced PCSC
niche factors Cxcl12 and Shh promote PCSC activation, lineage-specific differentiation, and POCR
regeneration. This central hypothesis will be tested in the following Specific Aims: 1) To characterize the
PCSC properties and their activation by injury; 2) To determine the signaling pathways that regulate
PCSC activation and lineage-specific differentiation during periodontal tissue repair; 3) To determine the
role of Cxcl12 and Shh in periodontal tissue regeneration in a periodontitis mouse model with more severe
inflammation. Successful completion of the aims will advance current knowledge of periodontal stem
cells and their regulation to provide new insights into prevention of PDs and promote predictable
periodontal tissue regeneration b y harnessing the natural ability of periodontal stem cells.

Public health relevance
Project Narrative The investigators will identify the previously unknown interactions between the stem cells in the periodontal crestal region and their niche during periodontal tissue regeneration. The proposed studies, based on previously published and recently unpublished novel findings, will have broad impact on understanding the molecular circuitry governing periodontal regeneration and significantly advance our understanding of how injury reshape the stem cell niche that regulates stem cell expansion and differentiation. The proposed studies will shed new light on promoting periodontal regeneration and treating periodontal diseases.